Idaho INBRE Program

PROJECT SUMMARY
The goal of the Idaho INBRE-4 Program is to continue to augment and strengthen Idaho's capacity to perform
and sustain biomedical research. This Team Science Supplement, Dynamic Cellular Events in Assembling the
Vertebrate Eye, will advance this goal by bringing together three University of Idaho (UI) investigators with
complementary expertise in developmental neurobiology, immunology/glial biology/imaging, and image
analysis/computer vision to address a key knowledge gap in biomedical science. Project co-directors will focus
on the development of the vertebrate eye, and therefore will be directly in alignment with the Cell Signaling
scientific theme of the Idaho INBRE-4 Program, as this organ carries out numerous developmental and functional
signaling activities. This Supplement project will pursue the spatiotemporal dynamics of relationships among
neuronal progenitors, neurons, glia, and non-nervous system cell types using live confocal imaging of developing
zebrafish embryos, and novel means of image/video analysis. The project will generate reference static and
dynamic atlases of vertebrate eye development over the time of retinal development/differentiation and create
image and video analysis tools for the vision science community for systematic and quantitative comparison of
eye phenotypes. These resources will be made publicly accessible and interactive and will utilize the INBRE Data
Science Core facility at the UI. This Core and its infrastructure were or are supported by IDeA (COBRE and
INBRE) awards and institutionally by the UI. The three project co-directors, DL Stenkamp, DM Mitchell, and L
Nguyen all have strong research records and have mentored numerous trainees. This Supplement furthers their
team approach and will provide preliminary data for future collaborative studies and competitive grant proposals,
complying with the goal of this funding Supplement. This team science approach will benefit each investigator
through their collective effort and bring new perspectives to address this key knowledge gap in developmental
biology. The project research questions do not duplicate those currently being pursued by the parent Idaho
INBRE-4 Program award. This Team Science Supplement to INBRE-4 encourages competitiveness that will
continue to have an enduring impact on biomedical research and training in Idaho.

Public health relevance
PROJECT NARRATIVE INBRE-4 will increase Idaho’s competitiveness in biomedical research and education. The statewide scientific Network will generate, complement, and enrich Idaho’s research capacity by mentoring new investigators, supporting research Cores, fostering regional collaborations, and providing student research opportunities.